Gene Regulation and Inheritance Program

GENE REGULATION AND INHERITANCE PROGRAM – PROJECT SUMMARY/ABSTRACT
The Gene Regulation and Inheritance (GRI) Program focuses on determining basic mechanisms governing
the regulation of gene expression and cellular inheritance at the molecular level, and on discovering how these
mechanisms are perturbed to influence the initiation and/or progression of cancer. GRI Program members share
an interest in uncovering the mechanisms governing transcriptional and post-transcriptional gene regulation and
DNA replication, and in understanding how gene networks and cellular plasticity are rewired in cancer cells.
While basic fundamental research continues as a major focus of the Program, a number of studies naturally
transitioned in a preclinical or clinical direction, in part stimulated by the strong strategic alliance with Northwell
Health, making patient samples and clinical discussions more accessible. The GRI Program has three main
research themes: (1) elucidating essential mechanisms governing the regulation of non-coding RNAs,
transcription, splicing, and genome inheritance; (2) determining how transcriptional and post-transcriptional
control are dysregulated in cancer; and (3) developing therapeutic agents and biological systems to target
transcriptional and post-transcriptional regulators. The Program is co-led by Leemor Joshua-Tor and David
Spector and includes 14 members. Since 2015, Program members have produced 121 papers (110 publications
and 11 preprints). Of these, 13 (11%) resulted from intra-programmatic collaborations, 32 (26%) resulted from
inter-programmatic collaborations, 77 (64%) involved collaborations with investigators at other institutions, and
44 (36%) were published in journals with an impact factor greater than ten. Among the 14 Program members,
12 (86%) co-authored at least one article with another member of the CSHL Cancer Center. Peer-reviewed
funding in the Program increased from $3.2 million in 2015 to $4.3 million in 2020. Program members are
supported by 14 R01-equivalent grants among 9 members. In the coming five years, Program members will
continue making novel insights into the mechanisms regulating RNA biology and cellular inheritance and
developing novel strategies to target these mechanisms as potential anti-cancer therapies.

Public health relevance
GENE REGULATION AND INHERITANCE PROGRAM- PROJECT NARRATIVE Not required per PAR-20-043